Shared Resource Management

PROJECT SUMMARY: SHARED RESOURCE MANAGEMENT
We propose to manage and provide support (space, funds, personnel) to eight Cancer Center Support Grant
(CCSG)-supported Shared Resources (Flow Cytometry, Advanced Microscopy, Structural Biology, Molecular
Biology, Pathology, Preclinical Imaging, Bioinformatics, and Biostatistics) that are necessary and highly utilized
by Cancer Center members. Shared Resources supported by the CCSG are configured and managed to provide
access to specialized state-of-the-art technologies, services, and expertise that enhance scientific interaction
and productivity in the Fred and Pamela Buffett Cancer Center (BCC) in a manner that ensures stability, reliability,
cost-effectiveness, and quality control of these services. The Director of the BCC, Dr. Cowan, makes final
decisions regarding the allocation of CCSG resources (space, funds, personnel) to Shared Resources. Dr.
Cowan is assisted by the Associate Director for Basic Research, Dr. Michael A. (Tony) Hollingsworth, who
manages policies and practices to ensure an effective and fair process for setting scientific and other priorities
regarding CCSG Shared Resource support and usage, and assuring accessibility to members across campuses.
Fiscal management and day-to-day administrative support for the Shared Resources is provided by Mr. Matthew
Winfrey, the Associate Director for Administration and External Affairs. Shared Resources supported by the
BCC are a subset of many Shared Resources available at UNMC and all Shared Resources supported by the
BCC are also supported in part by the Institution (UNMC), which allows us to leverage CCSG funds with
institutional assets and support. Our management plan for all resources is cooperative and collaborative with the
institutional oversight of UNMC-wide resources, which is housed in the Office of the Vice Chancellor for Research
(VCR), Dr. Jennifer Larsen. To ensure that supported shared resources are most effectively meeting the
research services needs of its members, the Buffett Cancer Center employs regular user satisfaction surveys to
evaluate quality, timeliness, upcoming needs, and comprehensiveness of shared resource service. Also,
communication from users regarding Shared Resource functionality is encouraged on an ongoing as-needed
basis for problems that arise in the daily operations of the resource. Dr. Hollingsworth and Mr. Winfrey conduct
an annual review of Shared Resources with each Manager (and associated personnel that conduct cancer
related activities). On an annual basis, subsequent to receiving results of the UNMC-wide and Cancer Center
specific surveys, reports of internal advisory boards, notes from presentations, and direct feedback from users,
Dr. Hollingsworth and Mr. Winfrey meet with the leaders of each Shared Resource to review usage, ongoing
and completed cancer related research projects, publications, grant support, quality and user satisfaction. We
also solicit input from each user and resource leader regarding the need for improvement in equipment,
personnel, or resources in order to maintain the state-of-the-art functional status for each facility. As part of the
surveys of users and managers, Cancer Center members are asked to identify current and anticipated needs
with respect to capabilities within the shared resources. Suggestions for new or enhanced resources are
reviewed and prioritized by leadership in the Cancer Center, including Program Leaders, Associate Directors,
and the Director. Funding plans (using Institutional or funds from sources other than the CCSG) for high priority
resources are developed and when possible enacted.